Immune Microenvironments and Hepatocyte Growth Factor Signaling Interactions in Breast Cancer Disparities

Modified Project Summary/Abstract Section

Segments of the population experience disproportionately higher breast cancer mortality rates, pointing to ongoing challenges in access to early detection, timely diagnosis, and effective treatment... A driving force in patient outcome is the type of cancer diagnosis and the available treatment options. We focus on two highly aggressive BC subtypes: the hormone receptor negative basal-like breast cancer (BLBC) and the under-studied and deadly inflammatory breast cancer (IBC). Subsets of the population often present with higher rates of BLBC vs. others, and since highly effective therapies are lacking, survival is poor. The NCI states IBC is more common and diagnosed in younger certain population of women and is often hormone receptor negative. Clearly a need to conduct more advanced studies into these lethal BCs, and their common themes, is critical for patient survival and understanding disparate outcomes. Many studies assessing population-based differences in BCs examine tumor characteristics; however, etiologic factors that lead to these differences in outcomes remain poorly defined. Our data show population specific immune and stromal cell infiltrate and altered protein levels within normal breast and tumor microenvironments. Our objective is to identify population specific mechanisms involved in the progression of aggressive, metastatic BC as a consequence of stromal effects at the site of the cancerous lesion.

Public health relevance
Modified Public Health Relevance Section A subset of breast cancer patients suffer disproportionately from higher mortality rates compared to others reflecting social, environmental and biological causes. We propose to identify mechanisms by which metastatic breast carcinomas tend to have worse outcomes in certain patients, focusing on cell-cell interactions between the cells that surround the tumor and the tumor itself. This research will provide a basis for developing new methods for targeting these aggressive breast cancers.